New Chemical Tools for Optically Controlled Protein Modification

Project Summary/Abstract
Biocompatible chemical transformations that are promoted by light have become powerful tools in chemical
biology by virtue of enabling spatiotemporal control over activity. Whilst genetically encoded photoactivatable
tools have become mainstays in the bio-orthogonal toolbox, light driven conjugation methods that effectively
interface with native biomolecular structures (no genetic encoding) under biologically relevant conditions, are
comparatively limited. In this project, we will evolve a method recently developed by our group for the
photobioconjugation of Tryptophan (Trp) residues using redox-active N-carbamoylpyridinium salts that engage
Trp in photo-induced electron transfer. We will show that, by carefully modulating the optical and electrochemical
properties of these reagents, that we will be able to both (1) dramatically enhance the kinetic capabilities of this
labelling reaction and (2) enable the discovery of new mechanistic paradigms that promote this labelling
chemistry. Moreover, we will demonstrate that, through careful manipulation of optical and electrochemical
properties of the N-carbamoyl pyridinum salt reagent, that we will be able to invoke mechanistic control over Trp
labelling in a wavelength-dependent fashion (i.e. we can control reaction mechanism with a given wavelength
of light). This, in turn, will allow us to design new application-based experiments that can both command precise
reaction outcomes and markedly expand the capabilities of photobioconjugation chemistry. Specifically, we will
harness this optical and mechanistic control for the design of new activity-based sensing applications as well as
through the design of proximity labelling approaches that we apply to the study of poorly understood processes
in mitochondrial dynamics.

Public health relevance
Project Narrative The overarching goal of this project will be to develop a sophisticated new set of light activated chemical reactions that selectively form covalent bonds with specific types of biological structure. These new reactions will serve to further advances in biomedical sciences by enabling the design of new synthetic-biological hybrid molecules as well as allow scientists to study the molecular nature of biological processes in new and unprecedented ways. This in turn can lead to the discoveries into the nature of disease states and, ultimately, into opportunities to develop new, more effective treatments.